Core E:Biomarkers Core

Project Summary/Abstract
The purpose of the Biomarkers Core is to provide an organizational model to accelerate the development and
approval of biomarker tests that link biology to clinical outcomes within SPORE projects and across other
Cores. This Core is focused on credentialing both imaging-based and liquid non-invasive assays to assess and
monitor disease status by characterizing the molecular and cellular features of a cancer as it changes over
time. Through the Biomarkers Core, the collection of human biospecimens is scheduled, collected, and tracked
under an IRB-approved clinical protocol. The process of consent, patient registration, and specimen collection
is undertaken in clinic, under the leadership of the Biomarkers Core. Applied to the clinic, the Biomarkers Core
efforts cover patients across the prostate cancer disease continuum. The Biomarkers Core will also conduct
under its leadership the three imaging protocols, for FDHT, PSMA, and DLL3 PET. This core complements the
other SPORE cores and MSK resources that include the Center for Molecular Oncology (CMO), Sloan
Kettering Institute (SKI), the Human Oncology and Pathogenesis Program (HOPP), Clinical Laboratories, the
Early Drug Development (EDD) Service, and other clinical services. Priorities for the Core are determined by
unmet needs in basic research, drug development, and clinical practice, with the objective of enabling more
informed diagnostic and therapeutic decisions so that patient outcomes are improved.

Public health relevance
Project Narrative Designed to complement both research projects and other Cores within the MSK SPORE in Prostate Cancer, the goal of the Biomarkers Core is to accelerate the development and approval of biomarker tests that link biology to clinical outcomes. This will enable more informed diagnostic and therapeutic decisions, so that patient outcomes are improved.